Mechanosensory substrates of flavor in the mammalian tongue

Project summary/abstract
Flavor is a multi-sensory percept involving taste, olfaction, thermosensation and mechanosensation. Such
flavor profiles affect food consumption and nutritional intake in humans. Behavioral and anatomical studies
provide strong premise for a role for oral somesthesis in flavor perception, and food texture has long been
appreciated as a cause of food rejection; however, mechanisms by which mechanosensory neurons influence
taste in the mammalian nervous system are poorly defined. Fundamental open questions include: what are the
identities of mechanosensory neurons in the tongue? What are the ion channels that underlie mammalian tongue
mechanosensation? The long-term goal of this research program is to elucidate how mechanosensory neurons
influence flavor perception.
We previously identified putative mechanosensory endings in the tongue through anatomical analysis, yet
our preliminary functional findings suggest that there are likely more classes of mechanosensory neurons
innervating the tongue. The Aims proposed in this project will characterize the anatomical, functional, and
molecular properties of tongue innervating mechanoreceptors (Aim 1), and identify mechanotransduction
channels that underlie tongue mechanosensation (Aim 2). We use a combination of mouse transgenic
technology, histology, in vivo calcium imaging, and tracing to carry out these Aims. Collectively, this research
will generate a comprehensive understanding of trigeminal mechanosensory neurons that innervate the tongue,
develop essential molecular tools needed for future studies on flavor perception, and provide a foundation for a
strong research program in the field of flavor biology. The work outlined in these Aims will also provide necessary
data for a competitive R01 application geared towards unraveling mechanosensory integration with flavor
circuitry in the central nervous system.

Public health relevance
Project narrative Textural aspects of food, termed mouthfeel, are important flavor qualities that can determine whether food is eaten or discarded, and thus, are essential factors for dietary health. Currently, little is known about the basic neuronal mechanisms underlying mouthfeel or the processes by which this flavor modality modifies taste. This work provides a comprehensive identification of mammalian mechanosensory neurons of the tongue and identifies mechanotransduction channels that underlie mouthfeel, with the long-term goal of understanding how mechanosensation impacts flavor perception.